Harnessing Cells from Human Milk; Linking Lactation to Metabolism

Project Summary:
Breastfeeding has been shown to protect mothers and their children from metabolic disease later in life. However,
maternal obesity and diabetes independently predict poor lactation outcomes, even after adjustments for
breastfeeding support and socioeconomic factors. The physiological reasons for this relationship remain unclear.
This proposal aims to identify the molecular mechanisms linking lactation to metabolism with a long-term goal of
developing interventions to improve lactation outcomes in women with obesity and/or diabetes.
Investigations of human lactation are challenging due to ethical and practical barriers related to accessing
mammary tissue in the lactating state. Single cell RNA sequencing of human milk-derived cells has shown that
these cells are remarkably similar to mammary epithelial cells (MECs) resident in the lactating gland. Additional
cell sorting efforts have established milk-derived MECs as “liquid breast biopsies” which may be used to answer
many outstanding questions regarding lactation biology.
Furthermore, a delicate balance of insulin signaling is required for MEC differentiation and maintenance.
Mammary specific knockout of the insulin receptor (mam-IRKO) blocks MEC secretory differentiation, and
therefore impedes lactation. Conversely, mammary-specific expression of an active form of insulin’s downstream
mediator, AKT, also drives lactation failure. In order to identify appropriate interventional approaches to improve
lactation performance, it is critical to understand if MECs are responsive or resistant to insulin in the context of
hyperinsulinemia. Studies of non-lactating mammary glands in women with obesity and diet-induced obese mice
suggest that premature insulin signaling may be responsible for these effects, by driving dysregulated glandular
development. The aims of this project are to 1. establish the effect of maternal gestational diabetes (GDM) on
MEC progenitor insulin signaling and milk-derived MEC profiles and 2. define the effects of insulin and other
metabolic hormones on MEC secretory differentiation and function.
Milk-derived MECs of women with and without severe GDM, matching for BMI, will be utilized to determine if
MEC progenitors from women with GDM are sufficiently responsive or resistant to insulin, and differences
between MEC populations which may explain impaired lactation outcomes in these women will be assessed. In
vivo and in vitro models of MEC development will be used to identify the mechanism underlying insulin’s effect
on lactogenic prolactin signaling, which is downregulated in mam-IRKO mice. Effects of adipokines leptin and
adiponectin on MEC development and function will also be investigated.
This proposal will inform future efforts to investigate additional links between obesity and/or diabetes and human
lactation dysfunction. The proposed approach has the potential to break a vicious intergenerational cycle of
metabolic disease. A collaborative team of experts in mammary physiology and diabetes in pregnancy will
support the applicant to ensure success of this innovative project.

Public health relevance
Project Narrative: Breastfeeding provides substantial protection against subsequent metabolic disease for mothers with obesity and/or diabetes and their babies, yet these women are at increased risk of inadequate milk production. The aims of this project will be to investigate the effects of maternal metabolic hormones on mammary development and function using cells derived from human milk and complementary in vivo and in vitro mouse models. Studies will be performed at a top tier program in lactation research and will identify interventional opportunities to improve lactation outcomes in an effort to decrease long-term metabolic risks for both mothers and their children.